Basic Research Support for the CCR

The Basic Research Program (BRP) provides scientific and technical expertise to NCI's Center for Cancer Research (CCR) in areas ranging from cancer and human immunodeficiency virus (HIV)/acquired immunodeficiency syndrome (AIDS), to the basic cellular processes underlying cancer, infectious diseases, and autoimmune disorders. Research topics supported by the BRP include: -Investigating ways in which novel, molecularly targeted cancer therapies can be used alone or in combination with immunotherapy in various tumor models (Molecular Immunotherapy Section, Cancer and Inflammation Program). -Understanding the genetic basis for resistance or susceptibility to disease conferred by human leukocyte antigen (HLA) class I and class II genes, which have a central role in the innate immune response (HLA Immunogenetics Section, Cancer and Inflammation Program). -Investigating the role of cytokines such as interleukin-7 (IL-7) in the development of T lymphocyte and natural killer (NK) cell lineages and their role in promoting cell survival, terminal differentiation, and apoptotic cell death (Cytokines and Immunity Section, Cancer and Inflammation Program). -Examining the role of dendritic cells, other innate or adaptive effector cell types, and proinflammatory or immunoregulatory cytokines on carcinogenesis and cancer therapy (Cancer Immunobiology Section, Cancer and Inflammation Program). -Support in bioassay development and screening, natural products chemistry, protein chemistry, molecular biology, and high-content cellular imaging to facilitate multidisciplinary, molecular targets discovery research (Molecular Targets Laboratory). -Discovery and characterization of renal carcinoma susceptibility genes (Urologic Oncology Research Group, Urologic Oncology Branch).